Integrated Care for Addiction, HIV and HCV Research and Education (ICAHRE)

The proposed program objectives are to: 1) Recruit and maintain a steady state of 11
highly diverse pre-doctoral trainees in our established training program focused on health
services research (HSR) related to addiction, HIV, HCV and implementation science; 2)
Mentor trainees in the conduct of clinical, outcomes, and implementation studies in HSR,
particularly related to integrated approaches to service delivery for substance use, HIV,
and HCV; and 3) Prepare trainees to disseminate research findings and translate them
into practice and policy as they launch careers in addiction-related HSR. Major advances
in HIV/AIDS treatment have made HIV a chronic, lifelong disease requiring ongoing care
and management; new developments in HCV offer dramatic opportunity for cure; and
new models of treatment for addiction have created the opportunity for significantly
improved outcomes in the midst of an opioid overdose epidemic. Addiction, HIV and HCV
commonly co-occur, requiring integration of care; few researchers have been prepared
to pursue this research agenda. We will continue a successful interdisciplinary pre-
doctoral training program, “Integrated Care for Addiction, HIV and HCV Research and
Education (ICAHRE)” within the PhD program in Health Services Research in the
Department of Health Law, Policy & Management (HLPM) at the Boston University
School of Public Health (BUSPH), in partnership with the Boston University School of
Medicine (BUSM) and Boston Medical Center (BMC). The formal training period will
encompass the coursework phase of the trainee's doctoral degree program, requiring
HSR theory and methods courses, enhanced by courses in addictions and/or infectious
disease, and implementation science. ICAHRE includes research seminars, research
rotations, and both didactic and experiential training in the communication of science to
multiple audiences. Mentored research training will lead to grant submission and
dissertation (PhD) completion. Given BUSPH’s focus on the underserved, long track
record of productive scholarship, strength in training and mentoring, history of
interdisciplinary collaboration, and institutional resources and leadership, we will
continue to train researchers to address some of our nation’s most challenging health
care problems. Our faculty brings substantial knowledge in addiction, HIV, HCV and
different approaches to HSR, including using both qualitative and quantitative research
methods.

Public health relevance
Addiction, HIV and HCV commonly co-occur which requires integration of care, and few researchers have been prepared to pursue this research agenda. We will continue a successful interdisciplinary pre-doctoral training program that encompasses the coursework phase of the trainee's doctoral degree program, requiring health services research theory and methods, enhanced by courses in addictions and/or infectious disease and implementation science, and including research rotations bringing trainees into clinical settings to apply mixed methods research. We are preparing trainees to disseminate research findings and translate them into practice and policy in these important areas.